PULSATILE GONADOTROPIN RELEASE IN PATIENTS WITH INSULIN DEPENDENT DIABETES

This study will address the issue of characterizing the pulsatile secretion of immunoactive LH and FSH and bioactive LH in women and men with insulin-dependent diabetes mellitus in order to provide information as to whether there is evidence for a hypothalamic or a pituitary defect in diabetic men or women.